A Multi-stakeholder Approach to the ELSI of Social and Behavioral Genomics: Investigating the Field's Downstream Implications to Mitigate Harms, Promote Benefits, and Locate Social Responsibility

PROJECT SUMMARY
This proposal addresses the ethical, social, and policy implications of an emerging, controversial field of
research: social and behavioral genomics (SBG). Using molecular, genome-wide data, SBG examines whether
and how genetic differences between individuals shape differences in traits and outcomes such as educational
attainment and math ability. Today, SBG is more accessible than ever. Members of the public can easily
acquire direct-to-consumer genetic tests for intelligence, math ability, and sexual promiscuity, among others.
Despite the growing availability of SBG data, few policies and incentives exist to consider SBG’s
downstream implications. Further, there remains a critical lack of breadth regarding who gets to define the
harms and benefits of SBG. As such, SBG engenders a host of difficult ELSI questions to be addressed by this
K01: What are the downstream implications of social and behavioral genomics as identified by a broader set of
stakeholders than ever before (i.e., SBG researchers, journal editors, journalists, members of industry, parents,
and educators)? What are stakeholders’ roles in producing, promoting, and/or mitigating the downstream
harms and benefits of SBG? How might the potential harms of SBG be mitigated against and its potential
benefits promoted? To address these questions, this proposal includes a plan of research that will achieve
three aims. Aim 1 will use in-depth, semi-structured interviews to investigate stakeholders’ (i.e., SBG
researchers, journal editors, journalists, members of industry, parents, and educators) roles in the conduct and
translation of SBG and their perspectives on the downstream harms/benefits of SBG. Aim 2 will adapt The
Ethical Matrix to determine stakeholders’ roles in producing, mitigating, and/or promoting SBG’s downstream
harms and benefits for the purpose of locating social responsibility. Finally, Aim 3 will draw upon deliberative
engagement theory and methods to design, implement, and evaluate a series of participatory sessions that
bring a selection of stakeholders interviewed in Aim 1 together to: (1) discuss (dis)agreements about Aim 1 and
2 findings; and (2) identify strategies for mitigating the harms and promoting the benefits of SBG.
Building on Dr. Martschenko’s strong background in mixed-methods education research, policy
development, and the ethical, legal, and social implications (ELSI) of human genetics/genomics, these aims
will be achieved with a career development plan that includes required training and coursework in science,
technology, and society (STS) studies and deliberative engagement theory and methods. Dr. Martschenko’s
career development plan will also strengthen her interdisciplinary ELSI networks. The career development plan
is supported by a team of esteemed, interdisciplinary scholars at Stanford University, The Hastings Center, the
University of California, San Francisco, and the University of California, Los Angeles: Mildred K. Cho (primary
mentor), Erik Parens (co-mentor), Janet Shim (co-mentor), Julie Harris-Wai (co-mentor), Barbara Koenig
(advisory committee), Aaron Panofsky (advisory committee), and Ben Domingue (advisory committee).

Public health relevance
PROJECT NARRATIVE Using an innovative multi-stakeholder approach, this study will contribute essential and timely data, new methods, and ethical analyses to first investigate stakeholders’ (i.e., social and behavioral genomics (SBG) researchers, journal editors, journalists, members of industry, parents, and K-12 educators) roles in the conduct and translation of SBG and their perspectives on SBG’s downstream harms/benefits. It will then determine stakeholders’ roles in producing, mitigating, and/or promoting the downstream harms benefits of SBG for the purpose of locating social responsibility. Finally, the proposed research will identify – through multistakeholder engagement – strategies for mitigating the harms and promoting the benefits of SBG.